Function of Metal Transporter ZIP14 as Regulated by Proinflammatory Stimuli

Abstract For This R56 Project Guiding Hypothesis: Zinc transport mediated by Zip14 (Slc39a14) influences gene expression in enterocytes that in turn alters intestinal barrier function. Goal: Evaluate mechanisms of enterocyte-specific Zip14 ablation and replacement zinc supplementation on epigenetic alterations including histone methylation and acetylation, transcription factor activation and lncRNAs and miRNAs that regulate genes in intestinal epithelial cells which influence barrier function.

Public health relevance
There is an ever-increasing body of evidence that zinc, an essential micronutrient in the diet, functions to help promote health through influencing a variety of cellular mechanisms, particularly signaling pathways. This project examines how the metal transporter Zip14, through mediated zinc transport influences intestinal barrier function, prevents the “leaky gut”, limits systemic inflammation and promotes intestinal health.